Training in HIV/AIDS Prevention and Treatment Research in Botswana

PROJECT ABSTRACT
The focus for this proposal is research training for people from Botswana in relation to the various uses of ART
for prevention and treatment in the modern era of the HIV epidemic. Recent advancements in coverage
strategies and antiretroviral combinations within the Botswana national ART program offer a unique
environment for use of modern HIV treatment, safety, and prevention research for the developing world, with a
host of research opportunities for training researchers in Botswana, to match current research activities of the
faculty mentors and key partners at the Botswana site. The in-country institution for this proposal is the
Harvard T.H. Chan School of Public Health, and our LMIC partner for training is the Botswana Harvard AIDS
Institute Partnership (BHP), a limited liability nonprofit corporation (LLC) with the Ministry of Health (MOH) in
Botswana. BHP is the largest HIV/AIDS research organization in Botswana, and one of the largest in Africa.
The long-term goals and objectives of this training program are to train research leaders for BHP, the
University of Botswana, and the MOH. Botswana currently has one of the highest prevalence rates of HIV in
the world (22%), but has also had the highest rate of antiretroviral drug treatment (ART) for patients with HIV
(about 90%) in Africa. The government of Botswana currently operates the most advanced HIV treatment
program in Africa, using a universal test-and-treat strategy. The training faculty at Harvard and BHP will focus
on how “modern” ART impacts treatment outcomes, safety, and prevention research.
HIV-related courses, seminars, and workshops are available for trainees. We have requested funds for 2
predoctoral and 3 postdoctoral positions each year. We estimate that we will train about 18 trainees over 5
years, allowing for multiple years for each PhD candidate and some postdoctoral fellows, and assuming
several short-term trainees could fill a single annual training slot. Stipends will be based on current degrees
and research experience; thus an MD on an MS or PhD program would be eligible for a postdoctoral-level
stipend. Each trainee will have a principal advisor and a faculty advisory committee. Selection of trainees is
based on previous academic performance, references, experience, and assurance that the candidates will
return to participate in HIV research in Botswana. The quality of the program will be monitored by a Training
Advisory Committee composed of experts from the US and from developing countries. The success of the
training program will be judged by the relative increase in senior research positions at BHP, UB, and MOH that
are individuals who were trained by this program after the second and fourth years. Success will also be
judged by the implementation of successful prevention research programs that involve trainees, numbers of
trainee publications in high-impact journals, and number of staff positions filled by former trainees at the BHP
and the Ministry of Health.

Public health relevance
PROJECT NARRATIVE Partnering with the Botswana Harvard AIDS Institute Partnership (BHP), a limited liability nonprofit corporation (LLC) with the Ministry of Health (MOH) in Botswana, we propose to create a training program focused on research for prevention and treatment of HIV/AIDS, especially emphasizing the several modern uses of ART, in Botswana, a country in southern Africa where HIV is of very high prevalence. Treatment for AIDS disease in Botswana has been effective, and a cost-effective prevention program is now the greatest need.